Capsid-engineered AAV vectors with Brec1-based gene therapeutics for inactivating the HIV reservoir

Abstract/Summary
People living with HIV (PLWH) continue to harbor virus-infected cells despite suppression by antiretroviral
therapy. These reservoir cells are the source of virus rebound that typically occurs in 1-8 weeks if treatment is
discontinued. Eliminating the provirus integrated in the genome of infected cells or the infected cells themselves
can cure PLWH. The recently discovered genome editing technique called CRISPR is being developed as an
approach to target and excise HIV DNA sequences present in infected cells. Large challenges to using the
CRISPR approach for HIV elimination are the wide diversity of viral isolates in PLWH and the risk of genotoxicity
as the Cas9 enzyme causes double-stranded breaks (DSBs) in the host chromosome. The absence of a targeted
delivery system for cells that make up the HIV reservoir increases these risks due to off-target effects.
This R01 application in response to RFA-AI-20-076: “New Technologies for the In vivo Delivery of Gene
Therapeutics for an HIV Cure” addresses the challenges posed by CRISPR-based gene therapy. We will use a
designer recombinase, Brec1, that has been developed to solely target HIV-1 provirus sequences and remove
these from the genome. 90% of the major HIV-1 subtype groups A, B, and C are expected to harbor the precise
Brec1 target sequence. Brec1 shows no immunogenic potential, does not induce cellular toxicity or display off-
target activity. We will in adition re-engineer Brec1 to generate a super-repressor called Brec1-Off that can
durably silence HIV transcription by epigenetically modifying HIV promoter sequences. Key to the success of
this approach is our development of capsid-engineered adeno-associated viral (AAV) vectors to deliver Brec1
and Brec1-Off specifically to human T cells and myeloid cells in peripheral tissues and the central nervous
system. AAV vectors are one of safest clinical gene therapy vectors that are approved for human use, albeit one
obstacle is their unselective delivery. We therefore redirect AAV tropism to the human immune cells in tissue
compartments which can harbor HIV-1 proviruses by deleting their natural receptor binding and engineering
specific target cell binders to their surface. Thus we pave the way to the development of a viable, non-invasive
approach for a gene therapy-based cure for HIV/AIDS.
The proposal has two specific aims-
In Specific Aim 1, we will develop AAV6 and AAV9 vectors with capsids modified to target human CD4 T cells
and myeloid cells and optimize their design for expression and delivery of Brec1/Brec1-Off to these human
immune cells as well as thoroughly assay AAV-Brec1 interventions in cell models of HIV-1 infection.
In Specific Aim 2, we will test the capsid-engineered AAV vectors packaging Brec1 and Brec1-Off in three
different physiologically relevant humanized mouse models for HIV infection to assess their ability to inactivate
peripheral and CNS reservoirs of HIV-1 that also contain the diverse HIV isolates found in PLWH.

Public health relevance
Project Narrative This project will use adeno-associated viral vectors guided by nanobodies or peptides to deliver HIV-1 specific recombinase-based effector molecules to inactivate the HIV proviral DNA in persistently infected human T cells and myeloid cells. The significance is a clinically-viable non-invasive systemic approach to kill HIV in all tissues including the CNS without harming the host.